Administrative Core

ABSTRACT The Chronic Rhinosinusitis Integrative Studies Program 2 (CRISP2) is an integrated program of
epidemiologists, otolaryngologists, allergists and immunologists in which highly collaborative studies are
proposed to better understand the molecular and cellular mechanisms of disease heterogeneity and how these
mechanisms translate into clinical phenotypes, natural history and long term outcomes. The program focuses
particular attention to CRS without nasal polyps (CRSsNP), a highly prevalent and yet obscure phenotype from
the standpoint of our current understanding. Another focus of CRISP2 is to critically evaluate the mechanisms
and consequences of comorbid conditions in which patients have both CRS and lung disease such as asthma
or bronchiectasis. Yet another theme is to make inroads in our understanding of why women are more
significantly impacted by CRS than men. In order to achieve these goals, the investigators that comprise the
CRISP2 study team have innovated new assays and approaches to cutting edge studies of pathogenesis and
epidemiology and, most importantly, have merged these two disciplines to relate mechanisms to symptoms,
severity, history and outcomes of CRS.
The Administrative Core (Core A) has as its main functions the goals of providing administrative support
for the vigorous integrative efforts of the program, facilitating communication and data sharing, catalyzing
publications and reporting of the findings of the work, ensuring that the Chronic Rhinosinusitis Integrative
Research Program-2 (CRISP2) promotes an effective training function and organizing the advisory board and
the regular meetings of the CRISP2 participating centers and investigators. Core A is also responsible for the
preparation of progress reports for the program and overseeing regulatory compliance with various institutional
and governmental agencies. Core A will play a central role in promoting synergy and advanced collaborative
interactions in the program. We have organized these and other functions into the following specific aims: 1.)
To provide central administrative services for CRISP2, including oversight of funds distribution, managing the
administrative office, facilitating changes that occur in budget, personnel or scientific direction, overseeing
preparation of progress reports and assurance of appropriate compliance with directives from the NIH, NU, UC,
G/JHU and local, state and federal agencies. The administrative team is Dr. Schleimer (PI), Ms. Valarie Thomas
and Ms. Seletta Nichols (administrators) and Dr. Alfred Rademaker (biostatistician). 2.) To facilitate
communications in CRISP2 and organize an advisory board. CRISP2 will have four quarterly meetings each
year and will maintain an internet-based cloud communications system. 3.) To disseminate discoveries made by
CRISP2. Core A will facilitate manuscript preparation and maintenance of a website. 4.) To encourage training.
Core A will support an ongoing grant program for young scholars. 5.) To promote interdisciplinary research.
Core A will facilitate interactions of the disciplines and individual investigators that are involved in CRISP2.